Novel Mechanisms that Restore Cardiac Parasympathetic Activity Limits Arrhythmias and Cardiac Dysfunction After Myocardial Infarction

Sudden Cardiac Death (SCD) is responsible for between 15 and 20% of all deaths, and ~50% of all
cardiovascular deaths in the United States. The most common cascade of events leading to SCD is acute
coronary syndrome (ACS) progressing to acute myocardial ischemia and/or inflammation that triggers electrical
instability and lethal arrhythmias. Preventing SCD is particularly difficult as approximately one-half of men and
two-thirds of women who succumb to SCD had no known history of prior heart disease. Autonomic imbalance
is a major risk factor for SCD. Augmented sympathetic activity induces changes in ECG repolarization and
reduction of fibrillation threshold facilitating the initiation of ventricular fibrillation (VF). In contrast, the
generation of fatal ventricular arrhythmias and risk of SCD is markedly reduced by increasing parasympathetic
activity. However a rapid, safe and feasible approach to increase parasympathetic activity to the heart in
patients at risk for fatal arrhythmias is severely lacking and is a major medical need. Our preliminary results
provide critical new information for the field that identifies a novel target that could restore parasympathetic
cardiac tone and reduce the incidence of arrhythmias and cardiac dysfunction following a MI. Our prior work in
subjects with sleep apnea has shown intranasal (IN) application of oxytocin increases parasympathetic cardiac
activity. In an animal model of ACS with ligation of the left anterior descending coronary artery (LAD) animals
develop ischemia, arrhythmias and mortality similar to clinical studies. We show that LAD-ligated animals have
reduced endogenous excitatory oxytocin-mediated neurotransmission to parasympathetic cardiac vagal
neurons (CVNs) in the brainstem. We further show that selective and chronic activation of hypothalamic
paraventricular nucleus (PVN) oxytocin neurons restores oxytocin release, increases parasympathetic activity
to the heart and substantially reduces the incidence and initiation of arrhythmias, inflammation, fibrosis and
other adverse cardiac outcomes. Based upon our novel results, our overall hypothesis is that chronic selective
activation of PVN oxytocin neurons, as well as nasal oxytocin administration, markedly reduces arrhythmias
and cardiac dysfunction in an animal model of ACS. In Aim 1 we will test the hypothesis that the critical
excitatory pathway from PVN oxytocin neurons to CVNs that helps maintain protective parasympathetic activity
to the heart is blunted in animals following LAD ligation, and that this key neurotransmission can be restored
with nasal oxytocin treatment and chronic and selective activation of PVN oxytocin neurons. In Aim 2 we will
test whether treatment by nasal oxytocin and chronic and selective activation of PVN oxytocin neurons
increases parasympathetic activity to the heart in-vivo, reduce the incidence of arrhythmias, improves
autonomic balance and effort capacity in exercise stress tests and cardiac function. In Aim 3 we will quantify
the electrical and mechanical function of ex-vivo perfused hearts to identify the mechanisms responsible for the
cardiac benefits of nasal oxytocin and selective activation of PVN oxytocin neurons in LAD-ligated animals.

Public health relevance
Sudden Cardiac Death (SCD) is responsible for between 15 and 20% of all deaths, and ~50% of all cardiovascular deaths in the United States. Autonomic imbalance is a major risk factor for SCD as augmented sympathetic activity facilitates the initiation of ventricular fibrillation (VF) whereas the risk of SCD is markedly reduced by increasing parasympathetic activity. Our goal is to provide critical new information for the field that tests a novel target for restoring parasympathetic cardiac tone and reducing the incidence of arrhythmias and cardiac dysfunction following a MI.